Investigating the cause of APOE4-associated microglial activation and its resulting neurotoxicity of tauopathy-afflicted neurons

Project Summary
Possession of the ɛ4 allele of apolipoprotein E (APOE) is a major risk factor for late onset Alzheimer's disease
(AD), although the direct cause remains a source of debate. Recent data has shown that the APOE gene is
upregulated in a novel microglial activation state found in AD and other neurodegenerative diseases termed
disease associated microglia (DAM). Furthermore, APOE4 expression has been shown to induce a neurotoxic
activation of microglia in the presence of various stimuli, including tauopathy-afflicted neurons, although the
mechanism of this activation has yet to be elucidated. In order to discover the role and mechanism of APOE4-
associated microglial activation and its resulting neurotoxicity of tauopathy-afflicted neurons, I have devised an
innovative set of experiments that utilize both cutting-edge technology and novel resources. In Aim 1, single-
cell RNA-sequencing will be performed on microglia purified from a novel mouse line in which human APOE3
and APOE4 mice are crossed with EC-Tau mice, which express a pro-aggregating mutant tau protein primarily
in the entorhinal cortex (EC). In Aim 2, APOE4's effects on microglial activation will be investigated in the
setting of human microglia, using both a newly created isogenic APOE human stem cell line and powerful
bioinformatics analyses. And in Aim 3, a robust in vitro co-culture assay will be utilized in order to both uncover
the mechanism responsible for APOE4-associated microglial activation and the resulting neurotoxicity and to
identify novel therapeutic strategies for inhibiting these events. As both APOE4 and microglial activation
significantly impact AD, discovery of the mechanistic link between these two important players and therapeutic
strategies for modulating APOE4-associated microglial activation would represent a major breakthrough in the
AD field and would greatly advance our goal of preventing or slowing the progression of AD, especially among
APOE4 carriers.

Public health relevance
Project Narrative Carriers of the APOE4 gene are at significantly increased risk for developing Alzheimer's disease. In order to understand the cause of this increased Alzheimer's risk, we will investigate a potential connection between this gene and another important player in Alzheimer's disease: microglial cells, whose activation has been linked to the death of tau-accumulating neurons in the brains of Alzheimer's patients. By performing state-of-the-art gene studies and bioinformatics analyses, we will determine the role that APOE4 has on microglial activation in the brain, which will help us understand how to better prevent and treat Alzheimer's disease in carriers of the APOE4 gene.